A multipronged, mRNA gene therapy approach to HIV cure

Abstract
CHALLENGE: Pathogen persistence within a host results in lifelong infection and causes significant
morbidity and mortality. Viruses that endure, like HIV-1, evade clearance by establishing latent infection and
escaping immune responses. Latency is a reversible form of nonproductive infection in which virus transcription
is suppressed. As such, latent viruses fly under the radar of the host immune surveillance. Previously tested
latency reversal strategies have failed due to inadequate potency and off-target toxicity. Further, HIV-1 evades
host immune responses through its extreme genetic diversity and direct immune dysregulation. While passive
antibody and cellular immunotherapy have shown promise in clearing virus, efficient, cost-effective delivery of
these interventions has hampered their use. “Kick and kill” cure strategies, which have not been effective to date,
seek to combine latency reactivation (“kick”) with interventions that clear reactivated virus (“kill”).
APPROACH: mRNA gene therapy has revolutionized vaccine development and is poised to address
shortcomings described above. As opposed to other technologies, mRNA does not come with risk of insertional
mutagenesis or require serologic prescreening. Importantly, its production uses cell-free procedures, remains
inexpensive at scale, and is both flexible and rapid. mRNAs encoding any gene of interest are delivered in lipid
nanoparticles (LNPs) that can be engineered to target specific cell types for timed, transient protein expression.
To address shortcomings in existing HIV Cure strategies, I have recently developed three novel mRNA-based
approaches: CD4-targeted delivery of the viral protein Tat, which drives HIV-1 transcription; hepatic delivery of
mRNA encoding monoclonal antibodies that are secreted into circulation; and chemokine-targeted mRNA
delivery to effector immune subsets. Here, I propose to develop these approaches as novel platforms that can
be combined into the first mRNA-only kick and kill cure strategy.
INNOVATION: In this application, I outline an interdisciplinary research program in which I design, study,
and apply cutting edge mRNA gene therapy to tackle previously insurmountable obstacles to an HIV cure. Using
all aspects of my clinical and scientific training, I have designed interventions grounded in an understanding of
both HIV-1 and human biology and tailored my delivery vehicle to suit this application. But, these approaches
will find application elsewhere; as they are developed, I envision applying these tools to disrupt viral
transcriptional programs, deliver pathogen-specific antibodies, and modify host effector cells as interventions
against other diseases. These novel mRNA-based approaches have the chance to translate the success of the
mRNA-LNP platform from vaccines to HIV eradication with the potential for worldwide use.

Public health relevance
Project Narrative Latency and immune evasion remain two major contributors to the chronic persistence of viral infections like HIV-1. Here, I propose a multipronged intervention that applies targeted mRNA gene therapy to reactivate dormant virus and promote adaptive immune clearance. These approaches, which directly stem from my multidisciplinary training, will develop investigative and therapeutic platforms with broad applicability.